2024 ICEMR Annual Workshop and Scientific Advisory Group Meeting

Project summary
The National Institute of Allergy and Infectious Diseases, National Institute of Health,
has established 11 international centers of excellence in malaria research (ICEMR).
This administrative supplement seeks funding for the Ethiopian ICEMR center to host
the annual workshop for the 11 centers and scientific advisory group (SAG) meeting for
Ethiopia and Uganda ICEMRs in Addis Ababa, Ethiopia. We will manage the scientific
program of the workshop, and facilitate the travel logistics of participants from all 11
ICEMR centers. The 5-day workshop and SAG meeting will include presentations by
individual ICEMRs on their scientific progress, information sessions on the ICEMR
program specific requirement, discussion sessions on common issues of interest and
break-out sessions on specific important scientific questions in malaria research and
control. The workshop will enable participants to share their latest discoveries, expertise,
experience, lessons, resources and protocols, and identify areas of inter-center
collaboration The SAG meeting will offer each ICEMR the chance to present their
progress to the SAG members, who will, in turn, provide critical feedback and
recommendations. Malaria is a very significant public health problem. The workshop
contributes to the malaria research and control efforts by facilitating data sharing and
collaboration among malaria researchers from different centers and regions, and
subsequently enhancing the development of new malaria diagnosis and control tools
and strategies.

Public health relevance
Program Narrative The Ethiopian ICEMR proposes to host the 2024 annual workshop for the 11 International Centers of Excellent for Malaria Research and scientific advisory group meetings for the Ethiopia and Uganda ICEMRs. The workshop will facilitate data sharing and collaboration among malaria researchers, and enhance the development of new malaria diagnosis and control tools and strategies.